Role of Skeletal Muscle in Pulmonary Vascular Remodeling

PROJECT SUMMARY
Pulmonary hypertension associated with heart failure with preserved ejection fraction (PH-HFpEF) is the most
common cause of PH worldwide, and at present, it has no proven effective therapies. Previously, we have
found convincing evidence that PH-HFpEF-regulating sirtuin-3 (SIRT3) is predominantly decreased in the
skeletal muscle. During the past grant period, we found a new endocrine signaling axis that links depressed
skeletal muscle SIRT3 to production/secretion of signaling molecules that interact with pulmonary vasculature
in PH-HFpEF. However, underlying mechanisms by which skeletal muscle SIRT3-mediated scretome regulates
pathological changes in pulmonary vasculature are not well-understood at present.
Based on a mass spectrometry-based plasma proteomics approach, our new data show that 2-microglobulin
(B2M) is present at higher levels in patients with PH-HFpEF. Both circulating and skeletal muscle levels of B2M
are markedly increased in mice with skeletal muscle SIRT3 deficiency. Plasma and muscle biopsies from a
validation cohort of PH-HFpEF patients also show higher B2M levels with increased disease severity.
Treatment with B2M recombinant protein reduces expression of WW domain-containing oxidoreductase
(WWOX), which plays a role in repressing cell proliferation, in PASMCs. B2M treatment also increases
expression of canopy fibroblast growth factor signaling regulator 2 (CNPY2), an unfolded protein response
(UPR) initiator known to induce excessive angiogenesis and proliferation, in PAECs. While B2M treatment
increases PAECs migration/proliferation and media conditioned by CNPY2-overexpressed PAECs reduces
WWOX in PASMCs, the role of PAECs CNPY2 in PH-HFpEF remains elusive. Thus, we hypothesize that
skeletal muscle-secreted B2M acts as an endocrine signaling molecule which induces remote pulmonary
vascular remodeling via dysregulating PAECs CNPY2 and PASMCs WWOX.
Specific Aim 1 will determine whether skeletal muscle B2M is an important signaling molecule affecting multiple
pulmonary vascular pathophenotypes. Using wild-type and skeletal muscle-specific B2m KO mice, with or
without high-fat feeding (HFD), which induces a PH-HFpEF phenotype, we will characterize the contribution of
skeletal muscle B2M in PH-HFpEF. In Aim 2, we will determine the role of PAECs CNPY2 in pulmonary vascular
remodeling and PH-HFpEF with EC-specific Cnpy2 KO mice. Specific Aim 3 will use plasma and muscle
biopsies of patients with PH-HFpEF or HFpEF alone collected from biobanks and Phase II clinical trials to
evaluate whether B2M can be a relevant biomarker of PH-HFpEF severity and prognosis. Inducible pluripotent
stem cell (iPSC)-derived ECs of PH-HFpEF patients will also be used to evaluate clinical relevance of CNPY2.
We expect that successful execution of the proposed research plan would provide new mechanistic
understanding of PH-HFpEF pathogenesis and aid in providing important information to guide future research
towards development of therapeutic approaches for the presentably untreatable PH-HFpEF.

Public health relevance
PROJECT NARRATIVE In this proposal, we aim to explore new mechanisms/communication routes by which skeletal muscle defects, via secreted endocrine signaling biomolecules, affect pulmonary vascular remodeling. As there are no therapies for PH-HFpEF treatment available at present, successful completion of the proposed work may provide important new insight into the mechanistic basis of PH-HFpEF pathogenesis, which may lead to the development of specific and effective treatments. The identification of circulating and muscle-specific molecular targets and their correlation with PH-HFpEF severity and/or disease progression/management may also aid in providing important information to guide future research towards facilitation of screening, diagnosis, refinement of specific patient phenotype, designing entry criteria for clinical trials in PH-HFpEF